Graduate Training at The Chemistry Biology Interface

Program Summary/Abstract: The mission of the CBI training program at the University of Maryland, Baltimore
County (UMBC) is to provide trainees with cutting edge research opportunities and hands on, cross-­disciplinary
training across not only discipline, but departmental lines. UMBC is a leader in promoting diversity within science,
technology, engineering, and mathematics (STEM) fields at both the undergraduate and graduate levels and the
CBI program has had significant success in producing strong and successful PhD students that have gone on to
excellent positions in academia, biotech and pharmaceutical companies, government agencies and patent law.
UMBC’s CBI program has four participating programs: UMBC’s Department of Chemistry & Biochemistry, the
Biological Sciences and Molecular and Cellular Biology programs, and UMB’s Pharmaceutical Sciences, The
CBI program was initially funded in 2004 with 15 students and has grown significantly since that time. Currently
there are 48 students participating in the program -­ 32 second year and beyond full members, and 16 first year
students. Of these, 43 are TGE and twelve are from underrepresented (UR) groups. Five students (4 are from
UR groups) are currently supported by the NIH training grant, however all of the full members (2nd year and
beyond) participate in the same programmatic requirements as those supported on the grant. The students
selected to be supported on the NIH grant are typically in their 3rd year and beyond to aide in having more time
to make progress on their cross training. There are also currently 43 participating faculty from the three
Departments.

The CBI program requirements include doing (i) hands on cross disciplinary research in a collaborator’s
laboratory that gives added value to the students’ dissertation research, (ii) taking an upper level course in
another discipline, and (iii) presenting at national and international meetings in addition to (iv) participating in the
weekly course, CHEM 715 “Issues at the Chemistry Biology Interface”. Because the students who are not
supported on the CBI grant still have to do the same requirements as the NIH-­supported Fellows, the PD has
leveraged the significant programmatic support provided by the three departments, the Dean of UMBC’s College
of Science and Mathematics, UMBC’s Vice President for Research and UMBC’s Provost, totaling $100K. This
provides travel and supplies money for the students to present their research at conferences, as well as to use
the funds for their cross training. In summary, the CBI program plans to continue to provide a meaningful training
experience for a large cohort of strong students to increase the depth, breadth and diversity of the biomedical
workforce.

Public health relevance
The mission of the CBI training program at UMBC and UMB is to provide PhD seeking trainees with cutting edge research opportunities and hands on, cross- disciplinary training across not only discipline, but departmental lines, in a number of health- and disease- related areas. The 48 participating students and 43 faculty come from the Chemistry & Biochemistry, Biology, Molecular and Cellular Biology and Pharmaceutical Sciences programs and are involved in many different areas of research. Some of the key training components involve hands- on, cross disciplinary research, taking a course in another discipline and presenting their research at national and international conferences, all activities that help lead to stronger, more competitive scientists for the biomedical workforce.